Contribution of chromosome versus gonadal sex to bone mass and strength

SUMMARY
Alzheimer's disease (AD) is a growing health concern and is the most common type of dementia worldwide,
affecting women with higher frequency. Evidence indicates that mental illness and neurological and nervous
system disorders can increase the risk of developing osteoporosis leading to high prevalence of bone frac-
tures. Fractures, in particular of the hip, have been associated with increased mortality, especially in the elder-
ly. Conversely, osteoporosis is associated with higher risk of dementia diagnosis. Yet, a direct link between
dementia and osteoporosis, frequently occurring with aging, has never been conclusively demonstrated. Inter-
estingly, some genetic mutations are risk factors for both AD and osteoporosis. For example, mutations of the
Triggering Receptor Expressed on Myeloid Cells 2 (TREM2), a molecule expressed in microglia in brain and in
osteoclasts in bone correlate with AD and dementia, and with bone fragility. Recent studies showed that mice
expressing the TREM2 R47H variant (TREM2R47H/+ mice) exhibit loss of TREM2 function and neuritic dystro-
phy. However, the mechanisms responsible for the TREM2 mutation effects on bone mass and strength are
completely unclear. We have shown that females TREM2R47H/+ mice exhibit low bone mass accrual compared
to wild type littermates, whereas no changes were observed in males. In addition, female, but not male,
TREM2R47H/+ mice exhibit low total and femur BMD at 5.5, but not at 4 months of age, compared to wild type
littermates. Yet, the mechanism by which aging has a stronger effect in female TREM2R47H/+ compared wild
type mice is not known. Our long-term goal is to understand the basis for bone sexual dimorphism. The ob-
jective of this supplement is to extend the original studies funded by the R21 award to a model of increased
risk of developing AD, with the aim to start uncovering the mechanisms for the increase susceptibility to devel-
oping AD in females. We propose to test the hypothesis that the differential skeletal consequences of ex-
pression of the TREM2 R47H variant result from a combination of gonadal and chromosome sex-
dependent mechanisms. To address this hypothesis, we aim to determine the contribution of gonadal
versus chromosome sex to bone mass and strength in 5.5-month-old wild type and TREM2R47H/+ mice.
Two Sub Aims are proposed. In Sub Aim a, we will examine the skeletal consequences of the TREM2 variant
in male and female mice and the role of chromosomal and gonadal sex at the structural, cellular, and molecu-
lar levels in wild type and TREM2R47H/+ XXM, XYM, XXF and XYF mice. In Sub Aim b, we will identify the cellular
mechanism that underly the sexual dimorphism in wild type and TREM2R47H/+ mice, by determining whether
osteoclasts from TREM2R47H/+ XXM, XYM, XXF and XYF mice are intrinsically different or respond to sex steroids
differently, and whether the pattern of osteoclastokines differs in a sex-dependent manner. These studies will
advance our knowledge of the mechanisms controlling bone cell function in a sex-dependent manner in the
context of increased risk to develop AD.

Public health relevance
PROJECT NARRATIVE The skeletal phenotype differs between males and females under physiological conditions as well as following genetic manipulations, such as in the TREM2 R47H model for Alzheimer's disease. However, whether the sex differences stem from presence of ovaries versus testis (and the corresponding sex steroids) or the presence of two X chromosomes versus one X and one Y chromosomes (or a combination of both gonadal and chromosome sex) remains unknown. Understanding the basis for these differences is crucial to developing approaches to prevent and reverse the loss of bone mass and strength, tailored specifically for females and males in the general population and in individuals with Alzheimer's disease and other dementias.